Summer Research in Vascular Surgery (SRVS)

PROJECT SUMMARY
Vascular surgery is expected to see a workforce shortfall in the future. This T35 program will expose
medical students to vascular surgery and the research that informs it. The aim is to meet the needs of
our aging population, satisfying the strategic vision of NHLBI including understanding human biology,
reducing human disease, developing workforce and resources, and advancing translational research.
Students will be selected from within the University of Pittsburgh School of Medicine. Recruits will
work on defined research projects that emphasize vascular biology and ways that research can
modify disease. They will also be exposed to clinical educational experiences that can help them
identify mentors for the future. Evidence suggests that mentorship is one of the most important
factors that influence students career choices in medicine. The goal is to have a representative
workforce that can take on the clinical and research challenges of vascular disease in an aging
population. In addition to laboratory or outcome research, students will attend clinical conferences,
research seminars and didactic lectures. They will be encouraged to submit abstracts and be part of
manuscript development. They will also have access to tuition benefits and travel expenses related to
their research. The researchers chosen as faculty as a whole have research priorities that are inline
with the eight objectives of NHLBI, including 1 - understanding normal biological function and
resilience 2 - investigating newly discovered pathobiological mechanisms important to the onset and
progression of heart, lung, blood and sleep related (HLBS) diseases 3 - investigating factors that
account for differences in health among populations 4 - identifying factors that account for individual
differences in pathobiology and in responses to treatments 5 - developing and optimizing novel
diagnostic and therapeutic strategies to prevent, treat, and cure HLBS diseases 6 - optimizing clinical
and implementation research to improve health and reduce disease 7 - leveraging emerging
opportunities in data science to open new frontiers in HLBS research and 8- developing, diversifying,
and sustaining a scientific workforce capable of accomplishing the NHLBI’s mission. The faculty
preceptors are from the Departments of Surgery, Division of Vascular Surgery, Vascular Medicine
Institute, Department of Cardiology and Department of Bioengineering. All are well funded with strong
mentoring histories in pre and post graduate experiences.

Public health relevance
PROJECT NARRATIVE Vascular surgery is expected to see a workforce shortfall in the future. This T35 program will expose medical students to vascular surgery and the research that informs it. The aim is to meet the needs of our aging population, satisfying the strategic vision of NHLBI including understanding human biology, reducing human disease, developing workforce and resources, and advancing translational research.